Indiana Clinical and Translational Sciences Institute

Since biobanks collect biosamples and health information from thousands of people, to be stored and used for
many years, this cornerstone of translational research is particularly dependent on public trust and acceptance.
Biobanks rarely communicate with donors after enrollment, however, and studies show that they often fail to
recall important facts about biobanking that are disclosed during informed consent. Coupled with increased
distrust of science in the United States, limited donor understanding creates dangers for biobank acceptability
and trustworthiness and limits donor engagement. In a public deliberation carried out in Spring 2024 by the
Indiana CTSI – partnering with a range of biobanks, researchers, and experts – a diverse group of 24
laypeople from across Indiana learned about these issues and made 15 recommendations. Among these
recommendations, deliberants emphasized that biobanks should communicate with donors regularly about
how the biobank collects and shares information, enters into partnerships with for-profit companies, and may
return individual results. Developing and testing ways for biobanks to provide increased transparency is an
essential step to help biobanks implement this recommendation and improve their trustworthiness and donor
engagement. The long-term goal is to increase the trustworthiness and effectiveness of biobanks. The main
objectives of this project are to use an iterative, user-centered design process to develop messaging and a
linked website for two partner biobanks, and then measure the impact on donor knowledge, trust, and
engagement. The rationale is that the messaging and websites will increase biobank trustworthiness and will
be used in phase two of the Indiana CTSI’s Clinical and Translational Research Program, where public
deliberation recommendations will be implemented widely to test impact on enrollment, trust, and other
outcomes. These objectives will be achieved by pursuing two specific aims: 1) Create messaging and a
website for two biobanks – using an iterative, user-centered design process – that discloses to donors how
data is collected and shared, partnerships with for-profit entities, and potential return of individual results to
donors. 2) Measure the impact of this messaging and website for donors to each biobank on knowledge of,
trust in, and engagement with the biobank. The proposed project is innovative because it will test the impact of
implementing a recommendation of a public deliberation, will expand the tools of Clinical and Translational
Science, and will create and test a novel method of biobank transparency. The project will significantly advance
the ability of biobanks to improve transparency and trustworthiness and increase donor trust and engagement.
The project will advance the aims of the Indiana CTSI, while going beyond activities proposed by the parent
grant. The project fits the goals of the Notice of Special Interest (NOT-OD-25-015) by supporting research on
bioethical issues that can inform future policy direction and bioethics research capacity and supports NCATS’
goal of addressing ethical issues that span disease domains and impede translational research.

Public health relevance
The proposed research is relevant to public health because it will develop methods to improve biobank transparency and trustworthiness, a potent way to increase donor knowledge and engagement. The project will thus support biobanks’ ability to support research, which will advance NCATS’ mission of using translational science to develop health solutions for a wide range of diseases and conditions.